Novel Kinematic Methods for Detecting Vestibular Loss in Veterans

Project Background/Rationale: The purpose of this proposal is to improve our techniques for
testing peripheral vestibular (inner-ear balance) function in Veterans. Vestibular loss is a leading
culprit for imbalance and falls, which are among the top reasons for health care visits and a
leading cause of mortality particularly in older people. Vestibular loss can be due to exposure to
ototoxic antibiotics or chemotherapeutic agents, trauma during otologic surgery including
cochlear implantation, aging, inflammatory or infectious processes, or other causes. In many
clinical situations, the detection of small losses in vestibular function could motivate alternative
therapeutic approaches or a change in surgical planning, thereby preventing the development of
further losses leading to potentially disabling symptoms. While current vestibular tests are good
at detecting large losses, they are not adequate for identifying more subtle lesions.
Project Aims: There is a need to develop new vestibular tests better able to identify small losses
in vestibular function. Here, we will investigate the ability of kinematic testing using inertial
sensors to meet that need. This technique analyzes the outputs of multiple body-worn sensors
recording movement and orientation of parts of the body while performing various activities. The
specific aims of this research proposal are to (1) develop improved test paradigms for collecting
kinematic data; (2) evaluate alternative kinematic sensor technologies; and 3) collect pilot data
for future large-scale comparisons of kinematic and conventional tests of vestibular function.
Project Methods: The first two aims of this 2-year pilot project will be accomplished by
comparing kinematic performance between normal controls (n=10) and patients with complete
unilateral vestibular loss (n=10). The third aim will involve patients at risk for minor vestibular loss
due to cochlear implant surgery (n=15). We will compare changes in their kinematic performance
during surgery to analogous changes in their conventional vestibular tests. Kinematic testing
methods will include measures of stance (movement of head and body while standing on foam in
the dark) and gait (head angular distance, velocity, and acceleration while rotating the head
about the yaw axis) while conventional tests will include video head impulse testing and cervical
vestibular-evoked myogenic potential. Subjective imbalance will be quantified using subjective
questionnaires. This will allow us to evaluate the relative ability of each testing modality to
identify minor vestibular losses.
Anticipated Impact: Completion of the proposed study will demonstrate that kinematic testing can
measure small changes in vestibular function inexpensively, simply, reliably, and accurately. This
will provide solid scientific footing for incorporation of kinematic testing into standard vestibular
testing paradigms. Results of this study will lead to a VA Rehabilitation Research & Development
Merit Award application exploring the applicability of kinematic tests to evaluating vestibular
function among patients with diverse causes for potential vestibular loss and establishing best
practices for monitoring vestibular function in sets of patients at risk. This research is highly
significant because successful completion of these studies will reduce the incidence of severe
vestibular loss and the impact of vestibular loss among Veterans.

Public health relevance
Loss of function of the peripheral vestibular system (inner-ear balance organs) is associated with an increased risk of injury from falling, decreased social confidence, greater isolation, and cognitive decline particularly in older Veterans. This can happen from aging, trauma, exposure to some medications, and other causes. Reducing the incidence of severe vestibular loss depends on detecting small changes in function before they develop into more significant problems. While current vestibular tests are good at identifying large vestibular deficits, they are not as successful identifying small losses. The purpose of this 2-year SPiRE application is to evaluate a novel technique, inertial-based kinematic sensors, for measuring vestibular function. Results of this study will be used as the basis for a VA Merit Award application further investigating how these techniques can be used to mitigate vestibular loss in Veterans.